Deciphering the Molecular Mechanism of Pediatric Interstitial Lung Disease to Advance Targeted Therapies

ABSTRACT
Pediatric interstitial lung disease (ChILD) is a rare and devastating lung disease for which there are minimal
disease modifying therapies. Often presenting in the first days of life with dyspnea and hypoxia, the clinical
course of ChILD is progressive respiratory failure. A key barrier to developing therapies is the lack of preclinical
modeling to interrogate the pathobiology. Many ChILD patients develop this irreversible disease from harboring
mutations in the alveolar epithelial type 2 (AT2) cell-restricted Surfactant Protein gene (SFTPC) that cause
protein misfolding. SFTPC-ChILD provides us the opportunity to develop preclinical models of ChILD with
which to decipher the molecular mechanisms of the disease and test therapeutics. We developed a robust in
vivo model of SFTPC-ChILD that recapitulates key clinical and pathologic features of the human disease. We
have used this model and human induced pluripotent stem cell (iPSC)-based AT2s (iAT2s) from a SFTPC-
ChILD patient harboring a misfolding SFTPC mutation to study the upstream AT2 events that initiate the
disease. During normal postnatal lung development, AT2s plays a critical role in the alveologenesis needed for
functional gas exchange through forming an ordered alveolar epithelium and by signaling with the developing
alveolar mesenchyme. The central scientific premise for this proposal is that SFTPC-ChILD AT2s lose their
critical lung development functions, and that gene-based therapies will restore these functions and protect
against the SFTPC-ChILD lung phenotype. Leveraging our Sftpc-ChILD mouse and iAT2s models we will
reveal how aberrant AT2s lead to ChILD. We will [Specific Aim 1] interrogate the anomalous development of
the epithelium in ChILD by defining the impact of Sftpc-ChILD expression on AT2 postnatal alveologenesis and
[Specific Aim 2] determine how Sftpc-ChILD AT2s orchestrate interstitial remodeling pathology through
signaling with the mesenchyme. We will also [Specific Aim 3] test early postnatal gene-based therapeutic
strategies to resolve Sftpc-ChILD AT2 dysfunction and ChILD pathology. When completed these studies will
not only heighten our understanding on ChILD pathogenesis, but also meet our goal of establishing gene
editing therapeutic approaches for a disease with limited treatments and no cures.

Public health relevance
NARRATIVE Pediatric interstitial lung disease (ChILD) is a rare and progressive lung disease presenting in the first days of life with dyspnea and hypoxia for which there are minimal disease modifying therapies. Many ChILD patients develop this irreversible disease from harboring mutations in the alveolar epithelial type 2 (AT2) cell-restricted Surfactant Protein gene (SFTPC) that cause protein misfolding and disrupt normal AT2 orchestration of lung development. Leveraging a novel mouse model expressing a human SFTPC ChILD mutation and SFTPC-ChILD patient-derived cell modeling we will charecterize how ChILD AT2s lose their critical lung development functions, and test early postnatal gene-based therapeutic strategies to resolve Sftpc-ChILD AT2 dysfunction and ChILD pathology.